Drosophila Clc-c model of Dent disease and human ClC-5 mutations

Project Summary/Abstract Mutations in the human 2Cl-/H+ membrane transporter, CLC-5, cause Dent disease, which is clinically characterized by increased renal excretion of low molecular weight protein (LMWP), Ca2+ (hypercalciuria), increased risk for kidney stones, calcification of the kidney tissue, and progressive renal failure by age 20-40. The involvement of CLC-5 in LMWP has been postulated and tested, but its role in renal Ca2+ mishandling is unknown due to the lack of an appropriate experimental model. I hypothesize that Drosophila melanogaster (i.e., fruit fly) may be an excellent model organism to study this Cl- transporter for the following justifications: (1) flies natively express a Cl- transporter (Clc-c) that is >60% identical to human CLC-5, (2) calcium crystal formation in fly renal epithelia recapitulate mammalian/human kidney stones and are easily induced for quantification in real time, (3) genetic manipulations in flies are easy, quick (i.e., one mating and progeny in 7- 10 days), and tissue-specific to allow for evaluation of in vivo function with mutated native or transgenic proteins, and (4) fly lines expressing genetically encoded fluorescent ion-sensors (H+, Cl-, Ca2+) allow assessment of in vivo ion transport. Our preliminary evaluations and experiments have identified that all known CLC-5 Dent mutations are conserved in the Clc-c sequence and that Clc-c and CLC-5 have similar voltage- dependent and ion-transport characteristics. In addition, knockdown of Clc-c in renal tubules increases calcium oxalate crystal formation compared to wildtype tubules, similar to increased kidney stone formation in Dent disease. In this proposal, I hypothesize that Drosophila Clc-c shares additional biophysical and phenotypical properties with those of CLC-5 and is similarly affected by mutations of conserved amino acid residues. My first aim proposes to compare the biophysical features of Clc-c to those of CLC-5 by using voltage clamp assessments, including determining the effect of homologous Dent mutations on the activity of the respective transporter. Second, I intend to evaluate Drosophila Clc-c in vivo. The second aim will be tested by (1) examining the cellular and subcellular localizations of Clc-c by antibody detection and of ions by expressing genetically-encoded ion sensors for Cl- and H+, and (2) comparing crystal formation and ion secretion in Malpighian tubules among WT flies and Clc-c knock-down flies by both in vivo and ex vivo methods. These results will determine if Clc-c is an efficient and effective model for studying the biological role in renal calcium and protein absorption of this Cl- transporter and Dent disease. The proposed fellowship training plan is focused on developing diverse technical perspectives and embellishing professional development activities that translate to a successful career in research.

Public health relevance
Project Narrative/Health Relevance Statement The human CLC-5, a renal chloride membrane transporter that is mutated in Dent Disease, has high homology to the Drosophila Clc-c with conserved amino acids in key regions. We intend to validate the function of Clc-c as a model for CLC-5 and to study conserved mutations that cause kidney stones in Dent disease. The proposed Drosophila model can then be exploited to determine the cell biology of this chloride transporter and its role in normal renal absorption of protein and calcium as well as the malabsorptions causing Dent Disease.